Communication quality during family meetings in the intensive care unit: how does quality impact health outcomes?

ABSTRACT
When poor communication between clinicians and family members of ICU patients, disparities related to social
determinants of health (SDOH), and a heightened distrust of healthcare professionals all coalesced during the
COVID-19 pandemic, “the perfect storm” emerged. Improving communication and trust in healthcare
professionals is critical in high-stakes ICU environments where the need for shared decision-making demands
that clinicians rapidly establish rapport and therapeutic alliance with family members of non-capacitated
patients. Many well-designed trials testing ICU communication interventions have had negative or minimally
impactful results, perhaps in part because we have only a rudimentary understanding of how SDOH impact
communication in the ICU, a clinical context where underrepresented individuals also suffer from disparities.
The goals of this R01 are to conduct a mediation analysis that will: 1) examine SDOH’s impact on
communication between family members and ICU clinicians; 2) identify mechanisms of action related to how
communication quality affects distrust of healthcare professionals and therapeutic alliance; and 3) determine
how these factors contribute to or mediate outcomes for family members of ICU patients. This longitudinal,
observational study will collect data from 320 family members from 5 ICUs serving underrepresented rural,
Black, and Hispanic communities in 3 states. Our primary health outcome is the provision of family-centered
care (as measured by the Patient Perceptions of Patient Centeredness questionnaire- Family Version).
Secondary health outcomes include family members’ psychological stress (anxiety, depression, symptoms of
post-traumatic stress disorder) and measures of patient ICU utilization (e.g., ICU LOS, ventilator days).
Mediating factors to be examined include communication quality, healthcare distrust, and therapeutic alliance.
Moderating factors include family members’ intrinsic traits (e.g., personality traits and decision-making style).
We hypothesize that: 1) poor SDOH yield poor outcomes and result in less attention to family-centered care
and worse ICU patient utilization outcomes; and 2) higher communication quality will improve the therapeutic
relationship and healthcare trust and result in improved attention to family-centered care and improved ICU
patient utilization outcomes among all patients regardless of SDOH. Using our results, we will adapt a
prominent conceptual model of communication to address the high-stakes communication needs of families
from underserved communities. Completing this work will advance the field by providing data to allow new
understanding of how SDOH and other factors (e.g., communication quality, trust) relate to provision of patient-
and family-centered care in the post-pandemic context. The knowledge gained will inform new content and
concrete communication strategies for future ICU interventions aiming to facilitate high-quality communication,
help to restore trust in healthcare, and improve therapeutic alliances in pursuit of achieving patient- and family-
centered ICU care.

Public health relevance
PROJECT NARRATIVE The COVID-19 pandemic exposed deficiencies in communication between intensive care unit (ICU) clinicians and family members and shed light on how social determinants of health (such as education/healthcare access, economic stability, and neighborhood environment) inequitably impact underrepresented populations (such as rural, Black, and Hispanic communities). This project will collect data to examine how communication quality, healthcare distrust, social determinants of health, personality traits, and other factors play a role in how communication unfolds in the ICU and their impact on patient- and family-centered care. When the research is completed, we will have a better understanding of how these factors impact health outcomes that will help us to develop and tailor interventions that address these issues and may improve the relationship between clinicians and patients/families as well as patient- and family- centered outcomes.